U.S. Health Surveys Microdata for Population Health Research

Summary
This proposal seeks continued funding to expand and enhance the IPUMS Health Surveys Project.
IPUMS Health Surveys provides streamlined access to core U.S. survey data on population health through
two integrated databases: the National Health Interview Survey (IPUMS NHIS) and the Medical Expenditure
Panel Survey Household Component (IPUMS MEPS). The NHIS is the leading source of information on U.S.
health, health disparities, and the social determinants of health; the MEPS is the primary source of information
on national trends and correlates in health care spending and health systems change. The proposed project will
further improve this crucial resource for pathbreaking research in four ways: (1) Expand the database. We will
integrate data and documentation from five new years of NHIS (2024-2028) and MEPS (2023-2027), nearly
doubling the number of MEPS variables we offer. (2) Lower the barriers to cutting-edge research. We will enable
rigorous and reproducible research by creating several complex variables critical for answering urgent population
health questions, including (a) the addition of MEPS family interrelationship variables to allow users to easily
attach information across records (e.g., parent to child, spouse to spouse); (b) harmonization of NHIS occupation
and industry information to support research on occupational health; (c) creating summary measures of health
insurance coverage instability over the course of the full MEPS panel; (d) bridging the substantial break between
ICD-9 and ICD-10 condition codes and creating simplified, policy-relevant categories to support analyses of
condition-specific health care expenditures using MEPS; (e) creating simplified MEPS prescribed medicines
variables so users can quickly identify broad categories of policy-relevant variables (e.g., generics, opioids); and
(f) improving the prescription medication data. (3) Enhance data access. We will enhance data access tools in
five ways: (a) enabling researchers to incorporate additional information (e.g., reason for visit, type of medical
provider seen) in the variables created through the MEPS variable construction system; (b) developing the
capability for users to easily create and download custom MEPS variables that summarize the complex
prescribed medicines data; (c) allowing extracts through the data access system with person-level data attached
to event- and condition-level records; (d) enabling analysis of customized datasets using our online data analysis
system; and (e) further simplifying access to user-defined summary variables by making them accessible through
our data extract Application Programming Interface (API). (4) Disseminate data to a broad, diverse spectrum of
users. We will engage in user support, training, and outreach activities to attract new users and support current
users. Activities will include conference exhibits, presentations, introductory workshops, virtual office hours,
timely answers to user queries, and webinars. We will also offer a three-day, in-person MEPS training workshop
geared towards early-career scholars and scholars from historically underrepresented backgrounds.

Public health relevance
Narrative IPUMS Health Surveys provides free, streamlined access to detailed, population-representative, individual-level data used by researchers to uncover sources of health disparities, to understand the mismatch between America's large health investments and poor health outcomes, and to examine the role of insurance coverage and access to needed care in improving population health and reducing health disparities. Continuing support for IPUMS Health Surveys will extend past and current health data infrastructure investments, allowing researchers to employ these rich yet complex data in scientifically rigorous and replicable studies of population health, health financing, and health policy.